Investigating Motor Neuron Disease in Spinocerebellar Ataxia, Type1

Spinocerebellar ataxia type 1 (SCA1) is a devastating neurodegenerative disease characterized by progressive
ataxia due to cerebellar degeneration, followed by progressive degeneration and premature death. Substantial
effort has been invested in determining the molecular mechanisms that lead to cerebellar degeneration. This is
largely due to the fact that impairment of these neurons leads to the first symptoms identified in SCA1 patients.
However, loss of cerebellar neurons alone does not account for the muscle weakness and respiratory failure,
which characterize SCA1 progression, and promote premature death. This knowledge gap prompts fundamental
questions about the pathogenic mechanism of premature death. SCA1 is caused by the expansion of CAG
repeats encoding polyglutamines (polyQ) in the ATAXIN1 (ATXN1) protein. The polyQ ATXN1 accumulates in
neurons forming nuclear aggregates ultimately leading to neuronal cell death. Of particular interest to the Orengo
lab is the role motor neurons play in SCA1. These neurons control skeletal muscle activity, and when diseased,
lead to skeletal muscle wasting, weakness, breathing dysfunction, swallowing difficulties and an inability to safely
clear the airway, all of which predispose to respiratory complications leading to premature death. Dr. Orengo
and his team hypothesize that motor neuron dysfunction in SCA1 is the main driver of premature death and that
the mechanisms leading to motor neuron degeneration in SCA1 are different than those involved in cerebellar
neuron degeneration. This distinction may be critical in the development of novel therapeutics that address other
affected cell types than just cerebellar neurons. Using a cadre of SCA1 mouse models, the Orengo lab will be
able to selectively turn on or off the expression of toxic polyQ ATXN1 in motor neurons and assess the molecular
and behavioral changes that follow. Specifically, the goals of this proposal are the following. (1) Assess whether
expression of polyQ ATXN1 in motor neurons is necessary for premature death in a conditional mouse model of
SCA1. (2) Determine the earliest, mid and late transcriptomic changes in motor neurons secondary to
autonomous and non-cell-autonomous polyQ ATXN1 expression. This investigation utilizes an innovative in vivo
approach, with dissociated motor neurons from the spinal cords of mice, sorting their nuclei based on a
fluorescent marker, and then deep sequencing the mRNA molecules present. (3) Explore the role of the master
transcriptional regulator Mdfi in a SCA1 mouse model and ascertain its affect upon the JNK/Jun signaling
cascade. Dr. Orengo’s proposed study is significant because it will shed new light on the role motor neuron
disease plays in SCA1, as well as what pathways are triggered within these neurons that lead to their
degeneration. Understanding these mechanisms will be crucial for developing more effective therapies that
address muscle weakness and premature death in SCA1 patients.

Public health relevance
Spinocerebellar ataxia type 1 (SCA1) is a progressive neurodegenerative disease, whereby individuals gradually develop incoordination, which progresses to being weak, short of breath, and culminating in premature death. This proposal aims to understand which brain cells are responsible for the premature death and what molecular changes within them lead up to their degeneration. Understanding these details are important for developing effective treatments for patients with SCA1.